Immunobiology of a novel human DAMP receptor, its murine homolog, & their ligand

Abstract
The immune system has evolved mechanisms to recognize and respond to cell injury and this
response contributes in important ways to both health and disease. In this process, alarm signals
called Damage Associated Molecular Patterns (DAMPs) are released from injured cells and these
are then detected by receptors on innate immune cells, which trigger sterile inflammation. These
responses are thought to be important for host defense, but also cause tissue damage that
contributes to a number of diseases. Because of this, it is important to identify the key DAMPs
that drive these responses and also the receptors that engage these ligands and mediate their
effects. While we and others have discovered a few DAMPs/DAMP receptors, it is clear that there
are others yet to be discovered. Moreover, the DAMP/DAMP receptors have been primarily
studied in mice and less is known about these in humans. This grant is based on our preliminary
discoveries of a novel DAMP receptor in humans, Clec17a, a related murine counterpart,
CD209f/g, and their novel DAMP ligand, GAPDH, which is highly conserved, broadly expressed,
and abundant. These discoveries form the basis for this grant. Our central hypothesis is that
Clec17a in humans and CD209f/g in mice are key receptors on innate immune cells that sense
the release of GAPDH from injured cells and help drive the ensuing sterile inflammatory response
and its associated pathology. We have 3 specific Aims to elucidate the structure and function of
this novel DAMP and its receptors. Aim 1 will elucidate in humans what innate immune cells are
stimulated by GAPDH, the nature and biology of their responses and the role of Clec17a in this
process. In addition, this aim will seek to determine the specificity of this response and how it fits
in with responses stimulated by other DAMPs. The importance of these goals is that they will
establish a novel DAMP-DAMP receptor in humans, elucidate their pathophysiology, and provide
insight into how humans recognize and respond to cell injury. Aim 2 will investigate the structural
and functional murine counterpart of human Clec17a, and elucidate its role, and that of GAPDH,
in mice. Aim 3 will elucidate the underlying molecular mechanisms by which human Clec17a and
mouse CD209f/g trigger innate immune cells and ultimately drive host defense and pathobiology.

Public health relevance
Narrative. This proposal seeks to elucidate how the immune system recognizes and responds to cell injury and death in ways that stimulate sterile inflammation and cause tissue damage. The proposed studies will investigate the role in these processes of a new signal (GAPDH) released from dying cells and newly discovered receptors that recognize this signal. The information gained by these studies may lead to new treatments to prevent or treat a number of diseases, including stroke, heart attacks, infectious diseases, and cancers.